Mechanisms of mTORC1 signaling to protein degradation pathways

The mechanistic target of rapamycin complex 1 (mTORC1) is the nutrient sensing machinery that plays
central roles in regulating cell growth and metabolism. Disturbance of mTORC1 functions is associated with
human diseases, such as cancer, diabetes, and neurodegeneration, and age-related pathologies. Despite
the recent progress in our knowledge on the mTORC1 pathway, how mTORC1 coordinates diverse
downstream processes remains poorly understood. Our recent studies revealed that mTORC1 actively
engages in regulating protein degradation beyond its role in autophagy. mTORC1 promotes a shift of
proteasome population to the immunoproteasome, an inducible type of proteasome, which facilitates
removal of a selective group of proteins. We also found that mTORC1 regulates degradation of plasma
membrane proteins, such as EGF receptor, via the endocytic pathway. These findings suggest that
mTORC1 has a broad range of functions in cellular protein degradation. Better understanding the expanded
roles of mTORC1 in protein degradation will have high impact in a wide range of research and will provide
novel insight into better therapeutic strategies to treat human diseases associated with mTORC1
dysregulation. The goal of our research program in the next five years is to determine the mechanisms
by which mTORC1 regulates protein degradation via three different pathways. First, we will define the
mechanisms through which the mTORC1-ULK1 pathway regulates autophagy induction, phagophore
nucleation, autophagic membrane fusion with lysosomes, and lysosome reformation. We will extensively
investigate the roles of mTORC1- and ULK1-mediated interactions and phosphorylations in regulation of
autophagy processes. Using cutting-edge cell imaging techniques and genome-editing tools, we will
determine dynamic changes of composition, recruitment, and localization/colocalization of endogenous
autophagy proteins during the formation of phagophore and autophagosome. Second, we will define the
mechanisms through which mTORC1 regulates the endosome-lysosomal pathway. We will identify key
endosomal factors and their interactions and phosphorylations regulated by mTORC1 and determine their
roles in endocytic degradation of cell surface proteins. Third, we will elucidate the roles of the
immunoproteasome in mediating mTORC1 signaling to regulate cell physiology and metabolism. We will
identify proteins that are preferentially digested by the immunoproteasome. We will determine the functional
significance of those preferential degradations, aiming to elucidate previously-unknown mechanisms for
cellular response to stress and growth signals. Through these directions of research, our research program
will advance the fundamental knowledge on mTOR functions in coordinating nutrient, growth and stress
status with the membrane-associated protein degradation pathways and the proteasome machinery, and
provide novel insight into the pathogenesis of human diseases associated with mTORC1 dysregulation.

Public health relevance
The research program will define the molecular mechanisms through which cells coordinate nutrient, growth, and stress conditions with protein degradation. The outcomes obtained from the study will provide key knowledge to develop better therapeutic strategies for human diseases, such as cancer, diabetes, and neurodegeneration, and age-related pathologies.